Advancing Science for the Diagnosis and Treatment of Gastroparesis

Summary
Gastroparesis and functional dyspepsia are common disorders that can cause chronic
nausea and vomiting, early satiety, postprandial fullness, abdominal pain, and
malnutrition that may require nutritional support. The broad objectives of this proposal is
to improve our understanding of these disorders and advance the ability to diagnose and
treat them. We propose to do this through three specific aims, as follows:
Specific Aim 1: To successfully conclude ongoing studies that are currently being
performed by the Gastroparesis Clinical Research Consortium.
Specific Aim 2: To initiate a new Gastroparesis Registry with inclusion of a larger
proportion of patients with idiopathic functional dyspepsia (GpR4 study)
Specific Aim 3: To characterize the role of aberrant macrophage activation in humans
with gastroparesis using pioglitazone (the “PIOGAS” study)
Through these aims, we will be able to conclude important ongoing studies (Specific Aim
1), expand the spectrum of gastroparesis by understanding its relationship to functional
dyspepsia (Specific Aim 2) and move closer to a cure for them (Specific Aim 3). Thus,
our goals are highly translational and of immediate and profound impact for the target
patient population.

Public health relevance
Relevance Gastroparesis and functional dyspepsia are disorders that predominantly affect younger women and have a very serious impact on quality of life and This research will help find new ways to diagnose and treat these conditions.